"Transcranial FUS therapy with closed-loop US image guidance and circulating tumor DNA

Project Summary
The treatment of patients with high-grade gliomas remains a major medical problem. Transcranial MR guided
focused ultrasound (MRgFUS) is a unique technology for noninvasive focal therapy in the brain. When enhanced
by microbubbles, FUS can promote the transient opening of the blood brain barrier (BBB) to improve drug
delivery in brain tumors. This technique can lead to more than 4-fold increase in the delivery and penetration of
a range of anticancer agents, including small molecular weight chemotherapeutics. Recent clinical trials have
confirmed the increased BBB permeability observed in preclinical models, demonstrated its safety, and provided
evidence of its efficacy. Despite these promising findings, the number of under-treated (i.e. moderate to low BBB
opening) and over-treated (i.e. MR-evident tissue damage) patients with FUS is above 40%, highlighting the
challenges for translation and the need for new methods and technologies for guiding this minimally invasive
intervention. An outstanding question in the field is how to map and control in the 3D space the microbubble
dynamics that mediate the BBB permeabilization but cannot be detected by MRI. This proposal aims to establish
novel closed-loop methods based on spectrally resolved passive acoustic imaging for mapping and controlling
the cerebrovascular microbubble dynamics through human skull. Moreover, by engineering an innovative
receiver array technology with high sensitivity, wide bandwidth, and adaptive active surface, this proposal will
provide the required signal-to-noise ratio (SNR) and directivity to detect the weak acoustic emissions generated
by the FUS excited microbubbles through human skull and throughout the brain. This array, which is amenable
to the proposed closed-loop methods, will be integrated to an MRgFUS phased array and used to characterize
the type and strength of microbubble vibration through human skull, expand the treatment window to theoretical
limits (i.e. single microbubble detection) and provide the ability to locally define and refine the exposure settings
during FUS interventions. In addition to optimum exposure settings for safe and robust BBB opening, longitudinal
assessment and quantification of the FUS-meditated changes in BBB permeability is crucial for identifying tumor
and drug-specific treatment windows. By recognizing that the transport across the BBB is bidirectional, it is
hypothesized that cancer soluble molecules can provide a simple, yet safe and effective method to longitudinally
assess the FUS-mediated changes to the BBB permeability and enable monitoring the response to therapy.
Thus, by integrating bioanalytical and computational methods, this proposal seeks to establish a minimally
invasive assay to guide FUS-interventions in the brain. If successful, the proposed methods, technology, and
findings, which will be tested in models of glioblastoma with a small molecular weight chemotherapeutic agent
and under clinically relevant conditions, will not only enable the delivery of tumor killing molecules to high-grade
gliomas but also facilitate the successful translation this potentially transformative FUS intervention to the clinics.

Public health relevance
Project Narrative This proposal will combine novel closed-loop image guidance methods with quantitative assessment of the secretion of cancer soluble biomarkers in body fluids to longitudinally assess Focused Ultrasound (FUS) targeted drug delivery and monitor the response to therapy. The proposed work, which will critically advance the FUS technology, aims to address critical barriers to the progress of noninvasive delivery of anticancer agents in brain tumors and facilitate the translation of this potentially transformative technology to the clinics.